Summer Program to Advance Research Careers (SPARC)

Summer Program to Advance Research Careers (SPARC) Summary
The Dana-Farber/Harvard Cancer Center (DF/HCC), in partnership with the University of Massachusetts
Boston (UMB), requests funding to address a predicted shortfall of college graduates in science, technology,
engineering, and mathematics (STEM) fields. We specifically address the need to ensure that more
undergraduates, especially those from underrepresented backgrounds, who start in STEM complete a STEM
degree and pursue careers in the biomedical and behavioral sciences. Via the proposed research education
program, Summer Program to Advance Research Careers (SPARC), we will provide an innovative and
engaging early research experience the summer after the first or second year of undergraduate enrollment that
sparks a student's interest in science and excitement about cancer and cancer disparities research by tapping
into pioneering work being done by DF/HCC and UMB investigators using emerging technologies.
Annually, 35 promising students from UMB and three of its feeder community colleges (Bunker Hill, Roxbury,
and Mass Bay) will be selected to participate during the summer following their first or second year. Each
student will be paired with a research mentor according to the student's background and interests. Faculty
mentors engaged in cancer and/or cancer disparities research using emerging technologies from the DF/HCC
and UMB communities will provide full-time, hands-on emerging technology research experiences that will
prepare participants to begin to successfully navigate the path to careers as cancer and cancer disparities
research scientists. The 12-week program will also expose students to the decision processes and skills
acquisition necessary for a successful research career. Students participating in SPARC will attend a variety of
seminars beginning at orientation and throughout their research experience—these will include both formal and
informal discussions on ethics and the responsible conduct of research.
SPARC will focus on three areas critical to the development of successful, innovative cancer researchers: (1)
acquisition of scientific knowledge in the area of cancer and emerging technologies; (2) development of
communication skills; and (3) individualized career preparation. Program activities in these three areas will
provide the strong intellectual, technical, and personal foundation essential for developing and implementing
cutting-edge research. Participant's academic and career progress will be tracked during the experience and
annually thereafter to assess the impact of the research education program on participants' interest in and
preparation for cancer and cancer disparities research.
1

Public health relevance
Project Narrative Title: Summer Program to Advance Research Careers (SPARC) The Dana-Farber/Harvard Cancer Center, in partnership with the University of Massachusetts Boston, requests R-25 funding to implement an intensive 12-week summer research experience focused on emerging technologies in cancer and cancer disparities for students at UMass Boston and its top community college feeders—Bunker Hill. Roxbury, and Mass Bay. The proposed research education program, Summer Program to Advance Research Careers (SPARC), aims to provide an innovative and engaging early research experience the summer after the first or second year of undergraduate enrollment that is focused on sparking student's interest in science and excitement about cancer and cancer disparities research by tapping into pioneering work being done by DF/HCC and UMB investigators using emerging technologies.